Research Training Program for Pediatric Subspecialty Fellows

This proposal requests continued support for the Research Training Program for Pediatric Subspecialty
Fellows at the University of Pittsburgh School of Medicine and UPMC Children’s Hospital of Pittsburgh (CHP).
The major goal of the Research Training Program is to identify, mentor, and foster the careers of future leaders
in pediatric research who are dedicated to improving child health through discovery. The program offers an
intensive research experience for pediatric fellows committed to training in either laboratory-based or patient-
oriented research relevant to child health. The training experience is designed to prepare fellows for careers as
independent, NIH-funded pediatric physician-scientists in the field of their choice. The Research Training
Program facilitates the training of fellows in subspecialties within the Department of Pediatrics that do not have
specialty-dedicated T32 grants (e.g., Adolescent Medicine, Cardiology, Endocrinology, Gastroenterology,
Genetics, Health Informatics, Hematology and Oncology, Infectious Diseases, Nephrology, Neurology,
Newborn Medicine, and Rheumatology) as well as those in subspecialties that have such programs (e.g.,
General Academic Pediatrics and Pulmonology) but are more limited in scope. Thus, the program maximizes
extramural support by targeting the most talented fellows in our large department and matching them with
outstanding mentors in a variety of disciplines. The mentoring faculty includes 36 outstanding basic,
translational, and clinical investigators who have distinguished records of research accomplishments and
mentoring. The emphasis of the mentoring experience is on the fundamentals of scientific inquiry combined
with the highest standards of excellence for rigor and integrity. Each fellow is expected to conduct an
innovative research project with the research team of one of the faculty mentors, leading to publications and
applications for individual career development awards. The Department of Pediatrics at the University of
Pittsburgh School of Medicine has a large and diverse pediatric research program and is housed on the CHP
campus along with the 300,000-square-foot CHP Rangos Research Center. We have appointed 31 fellows to
the Research Training Program at the University of Pittsburgh since its establishment in 2013; 26 will have
completed training by June 2024, and five remain in training. The outcomes of the Research Training Program
are encouraging for a program in existence for only ten years. Of the 26 program graduates, 81% are or will be
employed in academic positions (two associate professors, 18 assistant professors, and one instructor). These
graduates are supported by NIH awards, industry funding, and foundation grants, and several are applying for
additional NIH awards. These outcomes provide confidence that the Research Training Program selects
talented trainees, provides a superb team of mentors, and offers an intellectually stimulating environment that
inspires fellows in pediatric subspecialties and provides them with the experience and training to become
leaders in child health research.

Public health relevance
The Research Training Program for Pediatric Subspecialty Fellows at UPMC Children’s Hospital of Pittsburgh supports the training of physician-scientists who seek to improve child health through research. The broad public health significance of this program will be realized through the academic and scholarly accomplishments of the trainees, with connections to both the direct treatment of patients in the clinical setting and the discovery of disease mechanisms and new therapeutic agents.